Leveraging Large-Scale Biobanks to Discover and Define Rare Variant Effects in Hypertrophic Cardiomyopathy

SUMMARY
Hypertrophic cardiomyopathy (HCM) affects up to 1:200 individuals and is a common cause of sudden cardiac
death. Guidelines recommend genetic testing in HCM probands to help establish diagnosis, inform risk
stratification, and identify at-risk relatives. However, causal variants are identified in fewer than half of patients,
many tests return variants of uncertain significance (VUS), and genotype-phenotype associations of known
genes are insufficiently characterized to inform medical management. In this proposal we address 4 gaps in
HCM research: 1) Most data are from individuals of European ancestry referred for genetic testing, creating bias
in estimates of the contribution, penetrance, and phenotype in the broader clinical and community population. 2)
Established HCM genes have insufficient genotype-phenotype data to inform gene-specific clinical management.
3) The evidence for most candidate genes is equivocal due to lack of study in cohorts sufficiently large to evaluate
pathogenicity. 4) Some disease loci likely remain undiscovered because GWAS and linkage approaches used
in prior studies are not well-powered for diseases, such as HCM, with variable age of onset, both high genetic
and allelic heterogeneity, and incomplete penetrance. We will address these fundamental knowledge gaps using
innovative genetic methods and a novel, large-scale HCM research platform that includes harmonized
phenotypic, genotyping, sequencing, and identity-by-descent (IBD) data from six large biobanks comprising
~1.5M participants and >5,000 HCM cases. Specifically, we propose to use rare variant and IBD-based methods
to: Aim 1) Define the contribution and phenotypic manifestations of established disease genes in multiple diverse,
non-referral HCM populations; Aim 2) Assess the pathogenicity of candidate HCM genes with equivocal evidence
and establish a novel platform to evaluate VUS in established genes; and Aim 3) Discover novel HCM loci via
IBD mapping and rare variant association within and across biobanks at scale. To balance the innovation of
these aims, we present compelling preliminary data demonstrating the feasibility of our approaches which
identified a cluster of distantly related individuals harboring a common pathogenic variant in a Mendelian
cardiomyopathy gene. We anticipate these analyses will substantially expand our understanding of the genetic
factors underlying HCM risk and their clinical manifestations. Once established, our platform will support future
clinical and genetic research and advance the long-term goal of implementing targeted interventions at the clinic
and population level to reduce the burden of HCM for all patients.

Public health relevance
NARRATIVE Hypertrophic cardiomyopathy (HCM) is a highly heritable trait that affects up to 1:200 individuals and is a common cause of sudden cardiac death; yet causal variants are identified in a minority of patients, many tests return variants of uncertain significance (VUS), and genotype-phenotype data for established genes is insufficient to inform medical care. Harmonizing data from six large biobanks, we will use sequencing data and innovative approaches we have developed that leverage segments of the genome shared due to recent common ancestry to: 1) define the contribution and clinical effects of known HCM genes, 2) assess the pathogenicity of candidate HCM gene and VUS, and 3) discover novel HCM risk loci. These aims will fill important knowledge gaps in HCM clinical genetics, improve the yield and interpretation of HCM genetic testing, and inform gene- based precision care and screening.